Pain Management Collaboratory Coordinating Center (PMC3)

Project Summary / Abstract
The Pain Management Collaboratory Coordinating Center (PMC3) will (1) provide national leadership and
technical expertise in all aspects of research supporting the design and execution of high impact
Demonstration Projects that conduct cost-effective, large-scale, pragmatic clinical trials on non-
pharmacological approaches for pain management and other comorbid conditions in veteran or military health
care systems, and (2) make data, tools, best practices, and resources from these and other projects available
to facilitate research partnerships in VA and DoD health systems. The PMC3 will leverage the expertise of the
Pain Research, Informatics, Multimorbidities and Education (PRIME) Center of Innovation based at the VA
Connecticut Healthcare System (VACHS) and its partners at VACHS and Yale, including the VA Cooperative
Studies Program Coordinating Center/Clinical Epidemiology Research Center and the Yale Center for
Analytical Sciences and Yale Center for Medical Informatics, enhanced by a strong partnership with colleagues
at the Uniformed Services University for the Health Sciences Center for Rehabilitation Sciences Research and
a novel Military Treatment Facility Engagement Committee comprised of collaborating DoD and university
affiliated investigators, clinicians and educators devoted to facilitating successful pragmatic trials in DoD
settings. We will use our expertise in pain management, electronic health records (EHR), data systems and the
design and coordination of multi-site pragmatic trials to accomplish these objectives in collaboration with our
VA, DoD and Yale partners. To achieve these objectives, three specific sims will be addressed: Aim 1: To
develop, adapt and adopt technical policy guidelines and best practices for the effective design and conduct of
pragmatic trials; Aim 2: To work collaboratively with and provide operational, technical, design and other
support to Demonstration Project teams to develop, initiate and implement a research protocol; and Aim 3:To
widely disseminate NIH-DoD-VA Pain Management Collaboratory endorsed policies and best practices and
lessons learned within military and veteran health care systems. Achievement of these objectives and Specific
Aims promise to significantly accelerate the integration of evidence-based non-pharmacological approaches for
the management of pain into routine clinical care in military and veteran health care systems consistent with
key recommendations from the National Pain Strategy.

Public health relevance
PROJECT NARRATIVE On behalf of the NIH-DoD-VA Collaboratory, the Pain Management Collaboratory Coordinating Center (PMC3) will provide national leadership and serve as a national resource for development and refinement of innovative tools, best practices, and other resources in the conduct of high impact pragmatic clinical trials on non- pharmacological approaches for pain management and other comorbid conditions in veteran or military health care systems. We will use our expertise in pain management, electronic health records (EHR), data systems and the design and coordination of multi-site pragmatic trials to accomplish these objectives in collaboration with our VA, DoD and Yale partners.